3D Printed Silicon Nitride Porous PEEK Composite Spinal Cages for Anti-Infection

PROJECT SUMMARY
Spinal fusion is the standard treatment for persistent neck and back pain, but the hardware used to stabilize
the fusion can harbor or even promote bacteria that lead to persistent, difficult-to-treat infections that are costly
and damaging to patient health. Among the available materials for spinal fusion, polyether-ether-ketone (PEEK)
cages stand out due to their strength, biocompatibility, and radiolucency, but like other materials, they are
susceptible to spinal infections. Silicon nitride (Si3N4) spacers have been used in other spinal applications where
their rates of reportable adverse events due to infection are much lower than industry norms, but they are not
ideal for stabilizing spinal fusions due to their potential for subsidence and brittle fracture. To address this
challenge, SINTX used Phase I SBIR funding to develop and test a 3D-printed Si3N4-PEEK material that
incorporates the antimicrobial and osseointegrative properties of Si3N4 with the strength and elasticity of PEEK.
In this Phase II SBIR, SINTX proposes to use this material to develop a 3D-printed anti-microbial spinal fusion
cage that promotes osseointegration, withstands in vivo loading, and facilitates imaging. The project includes
long-term biomechanical performance and in vivo fusion property testing in both normal and contaminated
operative scenarios. Successful completion of these activities will position SINTX to prepare a 510(k) premarket
notification application for FDA. SINTX anticipates further development and commercialization of a 3D-printed
Si3N4-PEEK spinal fusion cage will provide orthopedic surgeons a high-performance fusion device that could
greatly reduce the incidence of fusion-associated infections.
Aim 1. Minimize potential design and manufacturing hazards by formal design and process risk
management analyses in accordance with ISO 14971. Milestone: Completion of the design FMEA and
process FMEA per ISO 14971 to minimize risks associated with the novel cervical cages and design freeze.
Aim 2. Verify that the finalized 3DP Si3N4-PEEK cervical cage meets the static and fatigue loading
requirements of ASTM F2077 and subsidence requirements of ASTM F2267. Milestone: Following the
design freeze in Aim 1, demonstrate static and fatigue compression, shear, and torsion strength and subsidence
resistance of the finalized 3DP Si3N4-PEEK’s porous cage meets or exceeds the guidelines for cervical cages
established by ASTM F2077 and ASTM F2267 and benchmarked for many cage manufacturers in the literature.
Aim 3. Determine antimicrobial activity (experimental arm) and in vivo biocompatibility and
osteointegration (biocompatibility GLP arm) for a 3DP Si3N4-PEEK cervical cage in a caprine model of
cervical spinal fusion. Milestone: Final, packaged, and validated implants will pass requirements in ISO 10993.
3DP Si3N4-PEEK implants will have biocompatibility, bone ingrowth, fusion, and resistance to infection
comparable to or better than control 3DP PEEK spinal cages.

Public health relevance
PROJECT NARRATIVE Up to 12% of spinal fusion surgeries fail due to infection, resulting in substantial personal and financial costs. This study is designed to complete the development of a spinal fusion device that includes a new composite of PEEK, a common material used to stabilize spinal fusions, plus silicon nitride, a medical implant material with excellent antibacterial and bone integration properties. Commercialization of an antimicrobial spinal fusion device is expected to substantially reduce the incidence of spinal fusion failure due to infection, potentially saving hundreds of millions of dollars annually and improving patient outcomes and quality of life.